Neural Correlates of Delayed Habituation to Faces in Social Fear

DESCRIPTION (provided by applicant): Habituation-defined as the decrease in response to the same information over time-is a fundamental process by which we learn about the environment around us. Humans must continually process vast amounts of incoming sensory information. Habituation is thought to play a role in filtering incoming information. As an individual learns that a stimulus in the environment is neither threatening nor rewarding, the stimulus becomes safe and familiar, resulting in habituation at both the behavioral and neural levels. However, failure to habituate to non-threatening stimuli in the environment may trigger feelings of uncertainty or unfamiliarity, resulting in fear and anxiety. Evidence in shy individual supports the hypothesis that habituation may be related to increased social fearfulness. For example, shy individuals are typically slow to acclimate to new people and objects, consistent with slower habituation. Additionally, our lab has recently shown that shy individuals fail to show habituation to novel faces in the amygdala and hippocampus, two brain regions associated with fear and evaluation of threat. However, no studies to date have been conducted exploring habituation in individuals ranging from low to high in social fearfulness. Because individual differences in habituation to social stimuli may provide an important neurobiological marker for risk for psychiatric illness, such as social phobia, we propose that exploration of habituation in individuals ranging from low to high in social fearfulness is critical. In order to study how the rte of habituation contributes to social fearfulness, we will recruit a group of individuals that range from low to high social fearfulness. Using functional MRI, we will measure neural habituation to repeated presentations of neutral human faces. We hypothesize that social fearfulness will be inversely correlated with habituation; individuals with higher levels of social fearfulness will fal to show habituation in several key brain regions that are involved in the expression of fear, including the amygdala, the hippocampus, the ventral and medial prefrontal cortex, and the fusiform face area. However, brain regions do not work in isolation; rather, processing of potential threats occurs over many brain regions that comprise a complex functional network. Therefore, we will also explore functional connectivity across each of these brain regions. As each of these key threat processing brain regions are both structurally and functionally connected, we hypothesize that habituation patterns will be reflected across regions within this network. Specifically, we hypothesize that prolonged communication (failure to habituate) between regions when viewing faces will be associated with higher levels of social fearfulness.

Public health relevance
PUBLIC HEALTH RELEVANCE: Although preliminary evidence has associated abnormal habituation in some brain regions with high levels of social fearfulness, little is known about how individual differences in habituation contribute to individual differences in social fear; therefor, this study will characterize the association between neural habituation and individual differences in social fearfulness. The results of this project will advance our knowledge about how the timecourse of brain activity leads to social fearfulness and anxiety. This new knowledge has the potential to guide individual treatment selection, identify individuals at highest risk for developng social anxiety, and serve as a marker of treatment efficacy. __SpecificAimsTextDelimiter__ Specific Aims Social phobia is a highly prevalent1-3, chronic4, and debilitating disorder5, and is a strong risk factor for other psychiatric disorders such as depression and substance abuse6. Early identification and effective treatment would significantly benefit public health. The availability of specific dimensional biological markers are essential for the early identification of risk and the assessment of treatment response7; however, clinically useful dimensional biological markers are currently unavailable. Our goal is to characterize a novel neural mechanism mediating individual differences in social phobia. We will use an innovative approach by studying the neural correlates of a dimensional trait-social fearfulness-which encompasses both sub-syndromal and clinical manifestations1;5;8-10. At the extreme end of the social fearfulness continuum is social phobia, a disorder which affects 1 in 10 people and is associated with reduced educational attainment, occupational status, and quality of life5. However, when clinical thresholds are shifted to include sub-threshold individuals, nearly 1 in 5 people are affected by significant levels of impairment as a result of social fears1;5;8-10. Because sub-threshold individuals experience similar reductions in educational attainment, occupational status, and quality of life as social phobia patients5, we propose that exploration of the continuum of social fearfulness is crucial. As dimensional measures are demonstrably helpful to clinically inform risk, severity, and appropriate treatments for psychiatric disorders7, understanding individual neural differences underlying social fearfulness will provide clinically meaningful information useful for early identification of risk, tracking effectiveness of treatment, and selection of individualized treatments. Previous neuroimaging studies of social phobia have focused on the magnitude of blood-oxygen-level dependent (BOLD) activity in response to social stimuli. While these studies have identified multiple brain regions involved in social phobia11, the critical next step is to identify how these regions contribute to individual differences. Differences in magnitude, which is usually measured as an average over time, may obscure differences in the persistence of neural response. As persistence of neural response may be a more specific indicator of individual differences than magnitude of response12;13, we propose to extend previous research by now examining the persistence of neural response, or habituation of response over time. Habituation is a fundamental learning process that signals safety and familiarity14-18, and preliminary evidence from our lab suggests that failure of neural habituation is associated with high levels of social fear19;20. We propose that individual differences in neural habituation, rather than overall magnitude of activity, are a key mechanism underlying social fearfulness. To test the hypothesis that neural habituation underlies social fearfulness, we propose to study a core set of brain regions that play a critical role in the processing and expression of anxiety and fear21-27: amygdala; hippocampal formation; ventral and medial prefrontal cortex (vPFC/mPFC); and fusiform face area (FFA). Current evidence points to an overall difference in the magnitude of BOLD activity in these regions in social phobia patients11;28-30; however, the temporal dynamics of BOLD response in these regions is unclear. We hypothesize that individuals with higher social fearfulness will fail to show habituation to a repeated social stimulus in key threat-processing regions. Because these brain regions comprise a structurally and functionally interconnected network responsible for processing visual social threat, our second goal is to explore functional interactions between brain regions. We hypothesize that individual differences in social fearfulness will predict rate of neural habituation in this functional network. Specific Aim 1: Determine whether social fearfulness predicts rate of habituation to faces in the amygdala, hippocampus, vPFC, mPFC, and FFA. We will use a functional magnetic resonance imaging (fMRI) task to investigate neural habituation to faces in 30 adults representative of the full continuum of social fearfulness. Habituation will be measured as the decrease in amplitude of BOLD signal to repeated presentations of the same face. We predict that social fearfulness will be negatively correlated with habituation to faces; individuals with high social fearfulness will show the slowest rate of habituation to faces. Specific Aim 2: Determine whether social fearfulness predicts patterns of functional connectivity between the amygdala, hippocampus, vPFC, mPFC, and FFA associated with social fearfulness. We will use functional connectivity analysis to identify interactions among this core network of brain regions. We will then test for a relationship between social fearfulness and functional connectivity within the network. We predict that people with higher levels of social fearfulness will show sustained signaling within the network, while people with lower levels of social fearfulness will show habituation across the functional network.